Myeloid Cells

? DESCRIPTION (provided by the applicant): Support is requested for a Keystone Symposia meeting entitled Myeloid Cells, organized by Arturo Zychlinsky, Judith E. Allen, Eicke Latz and Kate A. Fitzgerald. The meeting will be held in Killarney, Ireland from April 10- 14, 2016. Myeloid cells are essential in immunity: they control the interaction of the host with the environment and are indispensable in fighting infections and in the communication with other branches of the immune system. The introduction of new technology is revealing unprecedented levels of complexity in ontogeny, specialization, regulation and modulation of adaptive immunity by these cells. This meeting will cover topical questions in myeloid cell biology, including new concepts like the origin of myelocytes, trained immunity, epigenetic and genetic regulation of their function. It will cover myeloid cells of both bone marrow and fetal origin with an emphasis on how macrophages interact with other myeloid cells including granulocytes. There will also be an emphasis on clinical approaches including medical intervention. New approaches to understand the diversity and specificity of myeloid responses will be also included. The symposium will include different fields central to contemporary immunology both at the genetic and cellular level, including the instruction of the adaptive immune response by innate immunity in health and disease. It should therefore be of interest to both basic and clinical scientists working in cel biology, immunology and infectious disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Myeloid cells are essential in recognizing threats to the integrity of organisms - either infectious or endogenous - and in instructing other myeloid cells as well as other components of the immune system to respond to the threat. They are therefore essential in health since they jump start and orchestrate the immune response while also being efficient effectors, and are relevant in the defense of infectious diseases as well as in cancer. The Keystone Symposia meeting on Myeloid Cells aims to gather basic and clinical researchers including cell biologists, immunologists and pathogenesis experts, and generate an environment for discussion and the initiation of collaborations between scientists in different disciplines to direct research in myeloid cells, their origin and function in health and diseases.